Human Physiology Core

The Human Physiology Core provides state-of-the-art, cost-effective, centralized services for assessment of
biochemical analytes, human body composition and energy metabolism, insulin sensitivity, and beta-cell function
for diabetes-related research studies. Toward this end, the Core maintains instruments, collects and provides
quality control data, maintains and offers a web-based scheduling system, and provides staffing by trained
technical personnel for a broad suite of measures and services that can accommodate the needs of small pilot
studies and student projects up to large R01-level protocols. In addition, the Core promotes multi-disciplinary
research in diabetes across the UAB campus, and offers training, advice, and instruction to students, fellows, and
faculty. Lastly, the Core contributes to the development, evolution, and expansion of methodology in field of
diabetes at UAB by implementing and validating new technology and methodology. New technology offered in this
project period includes analysis of renal sinus fat from magnetic resonance imaging. Developmental work includes
use of dried blood spots for analysis of hormones from study participants providing remote samples. The Human
Physiology Core plays a central role in the DRC in the translation of basic research findings into an understanding
of human physiology and pathophysiological mechanisms causing diabetes and cardiometabolic disease.

Public health relevance
The Human Physiology Core helps diabetes researchers by providing state-of-the-art, cost-effective, centralized services for assessment of hormones, glucose, and lipids from humans and animals. The core also provides measures of human body composition, energy metabolism, insulin sensitivity, insulin secretion, and physical activity for diabetes-related research studies. In addition, the Core promotes multi-disciplinary research in diabetes across the UAB campus, and offers training, advice, and instruction to students, fellows, and faculty.